Integrative approaches defining the ontogeny, maintenance, and immune response dynamics of marginal-zone B cells

Project Summary
Strategically positioned as the gatekeepers between the circulation and the immune system, splenic marginal
zone (MZ) B cells form a frontline of defense against blood-borne pathogens. They mediate early protective
responses against diverse T-dependent and T-independent antigens, by employing strategies that blur the
boundary between innate and adaptive immunity. In humans, MZ B cell deficiency is linked to reduced IgM
titers and heightened susceptibility to sepsis and mortality related to encapsulated bacterial infections. In
addition, impairment in their function and localization is associated with several autoimmune pathologies.
Despite their importance, many aspects of the ontogeny and homeostasis of MZ B cells remain obscure.
The establishment and maintenance of MZ B cells in their splenic niche are determined by a complex set of
rules that regulate cell division, the influx of new bone marrow (BM) derived cells, death, and onward
differentiation. We hypothesize that the rules governing MZ B cell dynamics evolve as we age, and are
modulated significantly during immunogenic encounters, resulting in a profound variation in their niche size
and clonal composition. Here, we propose a unique integrative approach that synthesizes mathematical and
experimental strategies to quantitatively map the developmental trajectories of MZ B cells and dissect the
mechanisms that maintain their numbers and clonal diversity, across the lifespan.
Specifically, we will develop mechanistic mathematical models to describe the data derived from a validated
experimental system in which one can track the constitutive replacement within the MZ B cell compartment,
over long timescales in healthy mice. This approach will allow us to measure turnover, reveal any
heterogeneity within the MZ B cell pool, and define their developmental trajectories. Further, we will adopt
and extend these deterministic models to identify the rules governing the establishment of MZ B cell niche in
early life and formulate them as PDE systems to quantify the dynamic transitions in cells’ ability to persist,
as a function of time since their compartmental entry. Next, we will develop a dynamical modeling strategy
to map B cell differentiation pathways during immune responses, using novel mouse strains expressing an
antigen-inducible reporter gene and B cell-specific mutations in Notch2. Lastly, we will employ a
computational pipeline to study the single-cell immune repertoire and transcriptomic profiles of activated B
cells and to generate phylogenetic trees of antigen-specific clones as they diversify during immune responses.

Public health relevance
Project Narrative Marginal zone B cells are key players in defending against bacteria and viruses that enter the circulation; generating a reservoir of antibodies against common pathogens, and regulating tolerance to our own proteins and lipids. A quantitative understanding of their homeostasis will provide unparalleled insights into determinants that shape their pool size and clonal repertoire, across our lifespan and during immune responses. Leveraging or manipulating these determinants to modulate antibody-mediated protection – for example, to boost the efficacy of vaccines or potency of immune-regulative treatments – will have direct relevance to human health, guiding the development of therapeutics against systemic infections, immunodeficiencies, and autoimmunity.